SINGLE ORAL DOSES OF ACCOLATE (TM) IN CHIILDREN WITH ASTHMA

The purpose of this study was to investigate the safety and pharmacokinetics of single doses of Accolate (TM) in children ages 4 to 11 years with asthma. The study has been completed.